Building Implementation Science Capacity at Makerere University to Strengthen the Response to the HIV/AIDS Epidemic in Uganda

Project Summary
While Uganda is close to achieving the 90-90-90 targets, more than 27% of Ugandans with HIV remain with a
detectable viral load and the potential to substantially contribute to new infections. Uganda faces challenges with
HIV care and prevention, in particular for men, youth and geographically mobile subpopulations that continue to
fall short of viral suppression targets, putting them at risk for HIV complications, mortality, and onward HIV
transmission. With the aging HIV population there is increasing burden of comorbidities such as non-
communicable diseases (NCDs), and integration of NCD-HIV care is paramount to improve HIV outcomes.
Implementation science (ImS) research capacity is needed to optimize the public health impact of efficacious
interventions such as test-and-treat and pre-exposure prophylaxis (PrEP) for eligible populations.
Building on existing partnerships between Makerere University (MU) and its affiliated HIV programs and the
University of California, San Francisco (UCSF), we have established a pioneer ImS Research Training
Program at MU focused on enhancing the cascade of HIV care. We have built a strong foundation for ImS in
Uganda through training, integrating ImS as a field of study at MU and influencing HIV practices. We propose
to continue the Program and focus the next period on creation of sustained growth of ImS research
environment at MU and the application of ImS to bear on HIV research and service delivery on a larger scale in
Uganda. The specific objectives of our research training program renewal application are to: 1) strengthen the
scientific leadership and expertise needed for implementation science research by having increased focus on
PHD training at MU; 2) expand the breadth of training in ImS implementation science research at MU; 3)
optimize utilization of resources for training by leveraging the additional available resources in Uganda
(including projects funded by the NIH, European and Developing Country Clinical Trials Partnership (EDCTP),
President’s Emergency Plan for AIDS Relief (PEPFAR), and others; 4) strengthen trainee contributions to
evidence-based decision-making related to HIV prevention, care and treatment services through regular
interactions with policy makers and HIV program implementers; and 5) support the integration of ImS trainees
into Ugandan academic, research, policy and HIV implementing institutions to: a) pursue independent scientific
careers in ImS and b) strengthen use of ImS in HIV service delivery. The proposed ImS training program will
build on our relationships with UCSF faculty to provide a longitudinal mentorship program based on monthly
works-in-progress meetings (held virtually via online platforms). During our five-year program, we anticipate
training Ugandan trainees as follows: 4 candidates in PhD and 10 candidates in master’s degree programs at
MU, 40 candidates in a Post Graduate Diploma in Implementation science research and quality Improvement
and 6 candidates in the UCSF Online Certificate in ImS program.
1|Page

Public health relevance
Project Narrative. Implementation science (ImS) is key to addressing the persistent challenges to HIV elimination in Uganda, but research capacity is still limited. Building on existing partnerships between Makerere University (MU), its affiliated HIV programs and the University of California, San Francisco, we have established a pioneer ImS Research Training Program at MU, built a strong foundation for ImS in Uganda, and influenced practices along the cascade of HIV care. The Program focus of the next period is to create sustained growth of the ImS research environment at MU and the application of ImS to HIV research and service delivery on a larger scale in Uganda. 1|Page